Task A08: In Vitro Bacillus anthracis Lethal Toxin Neutralization Assay for Assessment of 5 Anti-Lethal Factor VHH Clones

This contract provides in vitro testing of potential anti-bacterial and anti-fungal agents, efficacy to combat the effects of toxins produced by bacteria and fungi, maintenance of bacterial, fungal and toxin stocks, and the development of related assays.